PRIDE-Functional and Translational Genomics of Blood Disorders

Abstract
The lack of diversity in US biomedical and behavioral science research continues to be a significant challenge.
To address this concern, the National Heart, Lung, and Blood Institute (NHLBI) funded the Summer Institute
Program to Increase Diversity (SIPID) in 2006. Subsequently, the Program to Increase Diversity Among
Individuals Engaged in Health-Related Research-Functional and Translational Genomics of Blood Disorders
(PRIDE-FTG) was established at Augusta University (AU). Through the PRIDE-FTG program, we have
provided mentored training for 114 underrepresented minority faculty. Mentees learned hands-on bench
research and grantsmanship skills during two consecutive Summer Institutes. Program evaluation supports
achievement of our primary goal of aiding mentees to submit an NIH or equivalent grant application within two
years of program completion; 42.3% of PRIDE-FTG mentees have NIH grant-funding as principal investigators.
In the next iteration of the PRIDE-FTG program, we included innovative components and collaboration with the
PRIDE-OHD (Obesity Health Disparities) and PRIDE-FOCUS (Future Faculty of Cardiovascular Sciences)
programs. We will test the hypothesis that a mentored training program to build research and grant-writing
skills will increase the ability of URM and disabled faculty, conducting blood disorders research to obtain
extramural funding and transition to independent research careers. Four aims will be accomplished: AIM 1.
Conduct innovative Summer Institute 1 at AU (Component 1). Mentees will participate in a grant-writing core
curriculum and hands-on-bench research training to enhance funding strategies. We will implement a K to R
Club to increase R series grant success. AIM 2. Support Small Research Project funding initiative (Component
4). In collaboration with the PRIDE Steering Committee and NHLBI program staff, we will fund pilot research
projects as administrative supplements to support competitive grant proposals addressing blood disorders
research. AIM 3. Facilitate Mentoring and Networking Activities (Component 2). Mentorship Committees
comprised of the mentee, PRIDE research mentor and home institution mentor will be established. Peer-
mentorship teams will launch within cohorts to promote collaboration. We will support a mid-year meeting at
AU to conduct a mock study section and mentee networking, and attendance at the PRIDE Coordination Core
annual meeting. AIM 4. Conduct innovative Summer Institute 2 (Component 3). Mentees will return to AU to
complete a one-on-one grant review to support the primary goal of the PRIDE program to submit an NIH or
equivalent grant application and participate in additional research experiences. The mentored training
supported by the PRIDE-FTG program will influence the number of underrepresented and disabled scientists
achieving successful biomedical research careers.

Public health relevance
Project Narrative The lack of diversity among the US biomedical research workforce remains a significant challenge. However, it is clear that expanding research technical skills combined with novel mentoring approaches are essential components of programs seeking to increase diversity. The Program to Increase Diversity Among Individuals Engaged in Health-Related Research- Functional and Translational Genomics of Blood Disorders, at Augusta University will address these challenges by providing intensive mentoring and research experiences, to develop competitive grant applications, and increase diversity of the US biomedical workforce.